BIOMARKERS FOR LONGITUDINAL ASSESSMENT OF CANCER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The goal of this pilot project is to design protocls required for evaluating progression/regression of tumor growth in a range of tumor models . More specifically we will optimize protocols that we will then apply in Phase II (longitudinal ) studies. We will optimize protocols on our 7T/GE MR Microscope for quantitative spin lattice relaxation (T2), quantitative diffusion, and 3D angiography (using liposomal GD). We will optimize a protocol for microPET using FLT (if the probe can be obtained) or FDG. We will explore the use of dual energy microCT as the capability to measure vascular fraction becomes available. Where possible we will couple the image based biomarkers to molecular, cellular, microvascular markers using conventional histology.